Neuroscience Gateway to Enable Dissemination of Computational And Data Processing Tools And Software.

Summary
The objective of this supplement proposal is to collect standardize provenance metadata of the Neuroscience
Gateway (NSG) datasets and computational tools using a provenance ontology, which will enable them to be
AI/ML ready. The NSG project began in 2012 to catalyze progress in neuroscience by reducing technical and
administrative barriers that neuroscientists faced in large scale modeling projects which require high
performance computing resources. NSG's success is reflected in the facts that its base of registered users
(currently 1370) has grown continually since it started operation, every year the NSG team successfully
acquires over 14,000,000 core hours of time on NSF funded supercomputers and it has contributed to large
number of publications and Ph.D./MS thesis. Starting in 2017 experimentalists and cognitive neuroscientists
began to use NSG for data processing/analysis and ML. NSG now provides over sixteen tools on
supercomputers for simulation, data processing and ML. As promised in the parent U24 grant awarded in
2019, we have enhanced NSG by adding new features making it an efficient environment for development and
dissemination of lab-developed neuroscience tools to the broader neuroscience community. It should be noted
that currently there is no provision to record metadata or provenance information for any of the NSG tools and
the data sets they produce. Currently the large number of NSG computational tools and the datasets lack
standardized annotations that is needed to enable them to be integrated into ML workflows with support for
explainable AI and reproducibility. In this supplement, we will first integrate a W3C PROV specification-based
provenance ontology in NSG through a provenance interface to allow users to record provenance metadata
using ontology classes. We will demonstrate the use of provenance ontology through a pilot project that will
use a neuroscience software called the NeuroIntegrative Connectivity (NIC) tool that analyzes EEG data to
compute functional brain networks in neurological disorders. The NIC tool has provenance metadata
characteristics built into it, and will be the first NSG tool to carry the metadata provenance information from the
beginning to the end of a dataset’s lifecycle. The ontology-based standardized description of both the NIC tool
and data will enable NSG to make them findable, accessible, interoperable, and reusable. In this context,
providing a secure method to efficiently share and verify the data and metadata is necessary for reuse of
scientific data. To achieve this, we will utilize the NSF-funded Open Science Chain (OSC) project which
provides a blockchain based solution to maintain the integrity and provenance for datasets and its metadata
and provides a way to perform independent verification of the data stored in the blockchain. The experience
gained via integrating a provenance ontology, the NIC tool and the OSC within the framework of NSG, will
allow us in the future to integrate metadata provenance information of other NSG tools and make the NSG
comprehensively more suitable for AI/ML workloads.

Public health relevance
Narrative The Neuroscience Gateway (NSG) enables large-scale computational modeling of brain cells and circuits used to study neural function in health and disease, analysis and processing of large data sets produced by advanced experimental methods in neuroscience, and dissemination of neuroscience software to the community. In this supplement project we will integrate the World Wide Web Consortium PROV specification- based Provenance for Clinical and Health Research ontology in NSG using the NeuroIntegrative Connectivity tool, to develop a framework for managing provenance metadata of NSG datasets and computational tools, which will make these tools and data AI/ML ready through standardization. The Open Science Chain project, which utilizes blockchain to securely store metadata and data, will be integrated with NSG to provide a secure method to efficiently share and verify the data and metadata necessary for reuse of scientific data.